Microscopy and Advanced Bioimaging

The TCI Microscopy and Advanced Bioimaging Shared Resource (MABSR) manages cutting-edge instrumentation and imaging strategies for the cancer community. The MABSR provides access, expertise, and consulting services for state-of-the-art super-resolution, light-sheet microscopy, and electron microscopy; in addition to confocal, multi-photon, and widefield microscopes. With TCI-focused staff, the MABSR collaborates with TCI members to develop advanced image analyses strategies and pipelines along with integrating new equipment and technologies based on TCI needs. A strong commitment to education is supported by participation in numerous campus-based and national initiatives, along with co-directing an annual graduate level microscopy course. As such, the MABSR offers complete imaging support from consultation, sample preparation, microscopes training, staff-assisted data capture, and high-performance computing workstations for image analysis. The Specific Aims of this Shared Resource are to: (1) Provide state-of-the-art equipment and services in microscopy and bioimaging based investigations; (2) Manage education, expertise, and training in the operation of instruments, advanced image analyses, and high-performance computing workstations.